Mechanisms of Androgen Receptor Transactivation in Recurrent Prostate Cancer

The androgen receptor (AR) is an essential transcription factor in prostate cancer development and progression that mediates its effects through interactions with coregulatory proteins. Melanoma antigen gene protein-11 (IVlAGE-11) Is an AR coregulator and IVIAGE gene member family of cancer-testis antigens expressed in androgen-dependent prostate cancer and overexpressed in castration-recurrent prostate cancer. MAGE-11 interacts with the AR Nl-l2-terminal FXXLF motif to increase AR transcriptional activity. Described in this proposal are studies to identify the mechanisms whereby MAGE-11 contributes to AR reactivation and promotion of recurrent prostate cancer growth. The studies test the hypothesis that MAGE-11 is a product of a proto-oncogene that increases AR transcriptional activity through interactions with the retinoblastoma pocket proteins, Rb and/or p107 (Rb/p107). Aim 1 in collaboration with Project 1 will establish the requirement for MAGE-11 in AR mediated prostate cancer cell growth using lentiviral vectors to silence and recover MAGE-11 expression. The cell cycle regulation of MAGE-11 and effects of MAGE-11 knockdown on the cell cycle, cell senescence and/or apoptosis will be determined. Lentiviral overexpression of MAGE-11 will be performed to simulate the cellular milieu of recurrent prostate cancer. Aim 2 pursues preliminary evidence that MAGE-11 sequesters the hypophosphorylated form of Rb/p107 to promote cell cycle progression. The ability of MAGE-11 to interact with Rb/p107 will be assessed with respect to the phosphorylation of MAGE-11 and Rb/p107 and the coregulatory effects of MAGE-11 and Rb/p107 on AR transcriptional activity. Aim 3 investigates functional effects of AR and MAGE-11 interactions with Skp2 (S phase kinase-associated protein 2) to modulate Skp2 activity and degradation, Rb/p107 effects on the Skp2-p27-Kip1 pathway and the E2F transcription factor-regulated gene network required for the G1/S transition. The studies are based on preliminary evidence that AR and MAGE-11 stabilize Skp2. The overall goal of the proposed experimental plan is to establish the mechanisms by which MAGE-11 contributes to the reactivation of AR to promote the growth and progression of prostate cancer.

Public health relevance
Prostate cancer is a multifactorial disease in which the androgen receptor (AR) and its coregulators have a central role. Recent studies identified MAGE-11 as a regulatory protein that links AR to cell cycle progression and prostate cancer cell proliferation. The proposed mechanistic studies may provide a basis for the development of new treatment strategies to arrest castration-recurrent growth of prostate cancer.